Excessive lipid metabolism in T cell senescence and immunosuppression

PROJECT SUMMARY/ABSTRACT
Current immunotherapies, including immune checkpoint blockage therapy and adoptive T cell therapy, have
resulted in promising results in certain types of cancer patients. However, these immunotherapies have so far
been insufficient to reproducibly eliminate tumors. It is clear that tumor-reactive T cells are suppressed and
dysfunctional in the suppressive tumor microenvironment that is a major obstacle for successful tumor
immunotherapy. Thus, dissecting the distinct mechanisms responsible for T cell dysfunctional states within the
suppressive tumor microenvironment should provide novel avenues for tumor immunotherapy.
We discovered that induction of T cell senescence is an important T cell dysfunctional state and a novel
suppressive mechanism utilized by both human naturally occurring and tumor-derived regulatory T (Treg) cells
in the tumor microenvironment. In fact, significant accumulation of senescent CD8+ T cells has also been found
in the tumor-infiltrating T cells (TILs) from various types of cancer patients. Importantly, we found that these
senescent T cells are functionally suppressive and molecularly distinct from anergic and exhausted T cellsand
that they are a critical mediator and amplifier for immune suppression within the tumor microenvironments.
Therefore, a better understanding of this novel suppressive mechanism and the molecular processes in
responder T cells suppressed by Treg cells is essential for the development of effective strategies to treat
human cancers. Cellular energy metabolism directs T cell survival, proliferation and their specific functions.
Different T cell subsets have different metabolic profiles. We have more recently identified that Treg-induced
senescent T cells exhibit active lipid metabolism, resulting in upregulation of lipid metabolic enzymes and
secretory lipid species, and accumulation of lipid droplets (LDs). The central hypotheses of this proposal are
that: 1) Excessive lipid metabolism is critical for senescence development and immunosuppression of effector
T cells mediated by Treg cells; 2) Senescent and dysfunctional tumor-specific T cells can be rejuvenated via
lipid reprogramming for enhanced anti-tumor immunity. Specific Aim 1 seeks to identify whether the excessive
lipid metabolism is involved in senescence development and immunosuppression of T cells induced by Treg
cells. Specific Aim 2 will explore the novel concept and develop effective strategies to overcome senescent
and exhausted tumor-specific T cells via lipid metabolism reprogramming combined with selective checkpoint
blockage therapy of anti-PDL1 for enhanced anti-tumor efficiency in the adoptive T cell transfer therapy tumor
models. The positive outcome of these studies should lead to novel strategies to reprogram lipid metabolism
and effector functions of tumor-specific T cells for cancer treatments.

Public health relevance
PROJECT NARRATIVE The proposed studies address the important issue of immune suppression and dysfunction of tumor-reactive T cells in the tumor microenvironment that is a major barrier for successful anti-tumor immunity and immunotherapy. The proposed research has relevance to public health, because it seeks to dissect a novel suppressive mechanism and then to develop critical strategies that control immune suppression and T cell dysfunction. Thus, the findings are ultimately expected to be applicable to improve the treatments against human cancers and other diseases as well.